Paradoxical roles of tumor lymphangiogenesis on tumor immunity and implications for immunotherapy - Resubmission 01

Project Summary
In melanoma and other cancers, the expansion of the local lymphatic network via expression of VEGF-C in the
tumor microenvironment promotes metastasis and is widely correlated with poor prognosis. We and others
have shown that VEGF-C-activated lymphatic vessels play important immune suppressive roles in the tumor
microenvironment. Paradoxically, we have observed that in mouse melanoma models, lymphangiogenic tu-
mors were more responsive to immunotherapy, including in adoptive T cell therapy, dendritic cell vaccines, and
protein vaccination. Here we propose a research program that explores this other side of tumor lymphangio-
genesis, and suggest a novel hypothesis that while VEGF-C in the tumor microenvironment can induce in-
flammation and immune suppression, it also enhances the infiltration of naïve T cell infiltration, at least in part
by upregulating the lymphoid homing chemokine CCL21. This enhanced infiltration, in turn, can prime the tu-
mor for enhanced responsiveness to immunotherapy. Three aims are proposed to explore (i) validation and
mechanistic underpinnings in mouse models, (ii) relevance to human melanoma, and (iii) translational applica-
tion.

Public health relevance
Project Narrative In this proposal we will explore the paradoxical roles of VEGF-C-driven lymphangiogenesis in shaping the tu- mor immune microenvironment.